Administrative Core

SUMMARY
The goal of the Administrative Core for the Stanford Vision Research Core grant is to provide overall
coordination, scientific and budgetary oversight to the P30 projects. The Administrative Core will continue to
foster and coordinate activities between the four Service/Resource Cores: (1) Advanced
Computing/Computational Core, (2) Device Design and Development, (3) Neurogenetics of Vision, and (4)
Imaging Structure and Function. The Administrative Core Director will liaison directly with the 4 Core Directors,
an internal Steering Committee, and an External Advisory Board to enact decisions made across these groups.
The Administrative Core Director will continue to ensure the functioning of the Administrative Core with the
following functions: 1) encourage entry into vision research by investigators not yet funded by the NEI, through
advertisement, collaborative meetings and quarterly presentations to the vision research community as part of a
new vision research minisymposium; 2) promote new collaborative activity by ensuring dissemination of new
approaches and technologies, transfer of reagents, and exchange of ideas across the campus; 3) maintain
scheduling for Core resources and an evaluative process for Core usage; 4) coordinate meetings of the
Steering Committee to oversee Core usage and overall strategy, budgetary decision making, and personnel
management, and coordinate meetings of the External Advisory Board to provide feedback on scientific
feedback and strategy to the P30 PI and Steering Committee; and 5) assure fiscal responsibility of the cores
to maximize breadth and utility in serving Aims 1 and 2 above.